A Clinic-Randomized Trial of a Clinical Decision Support System to Improve Dental Provider Delivery of Brief Tobacco Interventions and Quitline Referrals

Project Summary Use of clinical decision support (CDS) within electronic dental record systems (EDRs) holds much potential to improve the translation of current scientific evidence into clinical practice and improve the delivery of optimal, evidence-based, personalized treatment. Health care providers have access to evidence-based guidelines that help patients quit smoking. Translation of that knowledge and awareness into daily practice, however, remains low. This clinic-randomized trial will examine the rate at which dental providers deliver a smoking intervention and refer to a quitline when their EDR system includes health information technology-driven CDS compared with providers in control clinics without assistance from the CDS. Providers include experienced dentists and dental hygienists in private practices and predoctoral and dental hygiene students in dental schools. The primary outcome is a binary variable indicating whether the provider delivered a brief intervention or referral for treatment, as reported by the patient. Additional outcomes include patient self-reported actions toward quitting, smoking reduction, and smoking cessation. Provider-level barriers, facilitators, and potential mechanisms accounting for the effect of tobacco CDS will be examined. Using EDRs to translate current evidence into dental practice holds much potential yet is unrealized in both clinical training and practice. By leveraging the dental encounter as an opportunity to deliver smoking cessation, we can further decrease smoking rates, leading to improved population health.

Public health relevance
Project Narrative Smoking is a primary risk factor for periodontal disease and oral cancer, and more critically, remains the leading preventable cause of death in the United States. The overarching goal of this program of research is to reduce smoking-associated morbidity and mortality by increasing the number of patients who are referred for tobacco cessation counseling. This project is the next step in this program and aims to evaluate the effectiveness of clinical decision support (CDS) to improve dental provider delivery of brief tobacco interventions and referrals to tobacco quitlines for further tobacco counseling. The CDS will function within two commonly used electronic dental record systems. The CDS will generate personalized, evidence-based recommendations for dentists and dental hygienists to actively engage their smoking patients in the course of usual dental care. Subsequently, we will assess the tobacco cessation actions of smokers using patient- centered outcomes.